MRI cardiovascular catheterization applications

During the past year we have continued our work applying rapid MRI to guide simple and complex mechanical and biological interventions.

We continue to employ MRI catheterization as standard clinical practice at the NIH clinical center, based on our earlier careful pilot research comparison of conventional X-ray and wholly MRI guided transfemoral pulmonary artery catheterization in adults. We continue to enhance the capabilities of MRI catheterization to characterize heart function in patients. We have taught two dozen medical centers across North America and Europe how to adopt these techniques by hosting hands-on workshops in our labs at NIH.

We performed human cardiovascular guidewire catheterization using the new low-field and high-performance cardiovascular MRI system at 0.55T.

We continue to repurpose and develop purpose-built MRI catheter devices.

Overall we have successfully developed novel applications of real-time MRI for cardiovascular treatments, and we continue to build on clinical applications of these exciting new developments.